Health Literacy among Deaf ASL Users and Cardiovascular Health Risk

DESCRIPTION (provided by applicant): Michael McKee, MD is a deaf family physician whose career is centered on healthcare for deaf individuals who communicate in American Sign Language (ASL). Deaf ASL users are considered to be a linguistic minority group that is medically underserved with barriers and characteristics similar to what is found among many other linguistic minority groups. This group is also largely understudied which prevents progress in the Healthy People 2010's goals to reduce health disparities among minorities and disabled persons. Dr. McKee's goal is to become a leading expert and an independent investigator on the topic of health literacy among linguistic minority populations. He is most interested in studying the impact of poor health literacy on cardiovascular disease among Deaf ASL users. The unique environment of the CDC-funded Preventive Research Center: National Center for Deaf Health Research (NCDHR) at the University of Rochester provides a very ideal place for Dr. McKee to accomplish that mission. Rochester, New York, has been anecdotally reported to have the highest per capita deaf population in the United States. The large and active Deaf community in Rochester provides ample opportunities to evaluate and collaborate with to reduce health disparities. In order to achieve the goals outlined in the career development award, Dr. McKee will work closely with expert mentors to undergo a rigorous individualized curriculum plan that will provide further training in the fields of health literacy, deaf health, cardiovascular epidemiology, health disparities, survey methods, and advanced statistical analysis. With the guidance of mentors, consultants and preceptors, Dr. McKee will conduct a research project to further his research skills development and to obtain new and valuable information about the association of health literacy and cardiovascular health on Deaf adult ASL users. To determine the degree of association, a cross- sectional study will be conducted with Deaf ASL users and hearing native English speakers. Multiple tools and questionnaires will be used to compare study between Deaf ASL users and hearing native English speakers to better determine whether health literacy is lower among Deaf ASL users and assess its potential association with increased cardiovascular risk. Since no health literacy assessment tools exist for ASL users, an adaptation and translation of an existing health literacy assessment tool called the Newest Vital Sign (NVS) will take place. The adapted NVS will be the first of its kind assessment tool necessary for evaluating health literacy among Deaf ASL users. Measurements of English proficiency, health care access, and cardiovascular knowledge will be collected to determine its impact on cardiovascular health for both study groups. To determine the association of health literacy with cardiovascular health, we will utilize a non-laboratory based Framingham prediction score to evaluate the risk for cardiovascular disease for both the study and control group. By determining the prevalence and the degree of health literacy and its association with cardiovascular health risk in Deaf ASL users, we can learn how to better develop effective health literacy and cardiovascular health educational programs that are accessible in American Sign Language.

Public health relevance
PUBLIC HEALTH RELEVANCE: The overarching aim of this proposed Mentored Career Development Award is for Michael McKee, MD to become an independent health services researcher with a career focused on health literacy in linguistic minority populations including Deaf American Sign Language (ASL) users. The aim of the proposed mentored research project is to assess health literacy and its association with cardiovascular health among Deaf ASL users. (End of Abstract) Project Narrative The overarching aim of this proposed Mentored Career Development Award is for Michael McKee, MD to become an independent health services researcher with a career focused on health literacy in linguistic minority populations including Deaf American Sign Language (ASL) users. The aim of the proposed mentored research project is to assess health literacy and its association with cardiovascular health among Deaf ASL users. __SpecificAimsTextDelimiter__ 1. Specific Aims The overall goal is to identify the prevalence of poor health literacy and its associations with cardiovascular risk factors and outcomes among Deaf ASL users. This research focus will examine a potential cause of cardiovascular health disparities among Deaf ASL users, consistent with the Healthy People 20103 goals of reducing disparities among minorities and those with disabilities. Deaf ASL users have numerous barriers similar to other linguistic minority groups such as low English literacy, limited access to culturally competent health information, and mistrust of medical professionals and researchers. Despite the goals of Healthy People 2010,3 there remain markedly few research efforts specifically focused on reducing disparities among deaf ASL users. Part of the challenge in documenting these disparities comes from the lack of accessible health surveys and assessment tools for Deaf ASL users, which in turn, limits health educational programs which can effectively target disparities in health outcomes and health literacy. To the best of this investigator's knowledge, no other study exists that proposes to measure the health literacy level of Deaf ASL users and examines how this correlates with poorer cardiovascular health outcomes. As a result, the research plan will be both exploratory and hypothesis-driven. Below are the aims and objectives to be tested. Primary Hypothesis: Deaf ASL users have higher risk for cardiovascular disease than their hearing native English-speaking peers as a result of lower health literacy after controlling for gender, educational status, smoking status and age. Research Aim 1: To adapt, translate and validate the Newest Vital Sign (NVS- a health literacy assessment tool) for Deaf ASL users. Research Aim 2: Recruit 238 Deaf ASL users aged 40 years and older for the study group and 238 hearing native English speakers aged 40 years and older for the comparison group to be used in a cross sectional study design. Secondary hypothesis 1.a: The adapted NVS identifies low health literacy among Deaf ASL users. Secondary hypothesis 1.b: Deaf ASL users have lower NVS scores than their hearing English- speaking peers after controlling for educational status and age. Research Aim 3: Obtain self-reported English proficiency assessment for both Deaf and hearing participants. Secondary Hypothesis 1.c: Self-reported English proficiency is lower among Deaf ASL users than hearing participants after controlling for educational status and age. Research Aim 4: Assess basic cardiovascular health knowledge for both Deaf and hearing participants. Evaluate association between basic cardiovascular health knowledge with NVS scores for both Deaf and hearing participants. Secondary Hypothesis 2.a: Basic cardiovascular health knowledge is lower among Deaf ASL users compared to hearing participants after controlling for educational status, gender and age. Secondary Hypothesis 2.b: Low NVS scores correlate with lower self-reported cardiovascular disease knowledge. Research Aim 5: Assess non-laboratory based Framingham-like scores from both physical measures and self-reported measures for both Deaf and hearing participants. Evaluate correlation between non-laboratory Framingham-like scores with NVS scores for both Deaf ASL users and hearing participants. Secondary Hypothesis 3.a: Higher non-laboratory based Framingham-like scores are correlated with lower NVS scores for both Deaf ASL users and hearing participants. Secondary Hypothesis 3.b: Non-laboratory based Framingham-like prediction scores are higher among Deaf ASL users compared to hearing participants after controlling for educational status, gender, smoking status and age. Secondary Hypothesis 3.c: Non-laboratory based Framingham-like prediction scores are no longer different between Deaf ASL users when compared to hearing participants when NVS scores are taken into account. At the completion of the study, the disparities in health literacy will be better described among Deaf ASL users as well its role in cardiovascular risk disparities between deaf and hearing individuals.